Immune dysregulation mechanisms of persistent post-COVID19 olfactory dysfunction

PROJECT SUMMARY:
The sudden loss of smell and taste are among the defining features of COVID-19 that set it apart from other
viral respiratory syndromes with an incidence of up to 70% with some SARSCoV2 variants. Importantly, in
some patients smell and taste disturbances persist for longer than 12 months after recovery from COVID-19.
Furthermore, classical anti-inflammatory treatment therapies are ineffective for COVID19 chemosensory
dysfunction. To inform targeted treatments, it is critical to elucidate the specific pathways that lead to persistent
disruption of chemosensory function. Our preliminary data show that persistent COVID19 chemosensory
dysfunction involves persistently disordered neuroepithelial composition and infiltration with immune cells with
features of immunosuppressive macrophages. The dysregulated inflammatory milieu prominently features
linoleic acid metabolites and glioma-associated proteins with direct effect on olfactory stem cell proliferation
and differentiation and olfactory sensory neuron survival. This study will determine how the inflammatory but
steroid-resistant immune cells drive chemosensory dysfunction that plagues patients with persistent COVID19
disruption of smell and taste. In Aim 1 we will define the phenotype of the infiltrating immune cells using both
transcriptional and mediator studies. In Aim 2, we will determine how immune mediators defined in Aim 1
disrupt olfactory stem cell and sensory neuron development and apoptosis trajectories using a mouse in vitro
system and relate these findings to the disordered epithelial composition of subjects with persistent COVID19
chemosensory dysfunction. Thus, we use complementary approaches with molecular tools and cell systems
and samples from carefully phenotyped human subjects. The studies should reveal new potential strategies for
therapeutic development that are based on the novel underlying mechanism that we identified here.

Public health relevance
PROJECT NARRATIVE: Among the unique symptoms of COVID-19 are the abrupt and profound loss of smell and taste. While transient disruption of normal smell and taste is associated with many upper respiratory infections, the sudden onset and degree of severity are key distinguishing symptoms of COVID-19. Importantly, up to 4% of patients who recover from COVID-19 have persistently distorted sense of smell and/or taste 6-12 months later. Although current studies have identified disruption of the normal architecture of the olfactory neuroepithelium and of olfactory neuron signaling in patients with persistent COVID19 chemosensory dysfunction, the mechanistic determinants of persistence are still unclear. This proposal seeks to define the relevant mediators derived from uniquely dysregulated immune cells of patients with persistent COVID19 chemosensory dysfunction, the cellular targets of these mediators and how they disrupt the normal developmental and survival trajectories in the olfactory mucosa.